USDHub: community resource for Urinary Stone Disease research

ABSTRACT
Urinary stone disease (USD) is highly prevalent and contributes a substantial proportion of healthcare costs
related to kidney and urologic disease. Approximately half of children and adults suffer recurrent symptomatic
stone events, resulting in emergency department visits and surgery. More than a condition with episodic
occurrence of debilitating events, USD is a disorder of mineral metabolism with substantial morbidity, including
increased future risk of chronic kidney disease, fracture, hypertension, and cardiovascular disease. Despite the
high prevalence and burden of USD, advances in the understanding, treatment, and prevention of USD have
stalled due to deficiencies in available data resources. These critical gaps include lack of clinically important
information, lack of longitudinal data, reliance on single-center designs that segregate pediatric and adult
patients, and exclusion of key stakeholders in database design. To address this need, this proposal creates the
Urinary Stone Disease Hub (USDHub), a readily accessible research resource for the broad research community
that would support a wide range of impactful clinical investigation to improve the health of children and adults
with USD. USDHub will generated from 10 health systems in the United States that participate in STAR and
PEDSnet, two PCORnet clinical research networks that have standardized electronic health record data. We
will ensure that the content and structure of USDHub has value to the USD research community by including
stakeholders, including patients and caregivers. This work will include the following three Aims: First, we will
create a research cohort of >230,000 individuals across the lifespan with USD. We will link extant structured
data from the PCORnet common data model to 24-hour urine results and stone composition data. Second, we
will enrich USDHub with information extracted from CT images and clinical notes using natural language
processing and machine learning methods. Third, we will broadly disseminate USDHub to researchers using
sustainable data access model. We will partner the USD research community to user test and refine the data
access process. To maximize USDHub’s impact, we will provide pilot grants, clinics to orient researchers to
USDHub data, and partner with professional organizations to disseminate USDHub to the broader USD research
communities. The outcome of this work will be a new research ecosystem for investigators to generate impactful
real-world knowledge that will transform the way USD research is conducted and thereby improve care and
outcomes for the growing number of individuals living with the disease. This resource will spur and accelerate
hypothesis-testing research and lead to impactful and clinically meaningful discoveries that improve the health
of individuals and populations with USD across the lifespan.

Public health relevance
PROJECT NARRATIVE Urinary stone disease is a common and painful condition with substantial morbidity. There have been few advancements in the diagnosis and management of urinary stone disease, which is due in part to lack of datasets that contain clinically important information about individuals with urinary stone disease across the lifespan. In this project, we create a data resource to strengthen urinary stone disease research that will generate new knowledge that improves the health of all individuals with urinary stone disease.